From mtDNA stress to cellular immunity: Triggers, Mechanisms and Effectors

PROJECT SUMMARY: Mitochondria are the evolutionary product of the endosymbiosis between the ancestral
eukaryotic cell and an obligate aerobe bacterium, which brought new functionalities to eukaryotic cells. During
their evolution, mitochondria transferred more than 99% of their known genetic material to the nucleus – with the
exception of a small, multi-copy genome referred to as mtDNA. In Homo sapiens, the 16.6 Kbp of mtDNA is
circular and encodes for 13 members of the oxidative phosphorylation chain (OXPHOS) and other structural
RNAs. Beyond their canonical role in the generation of ATP through OXPHOS, the mitochondria are also critical
stakeholders in several cellular processes from metabolite fluxes and calcium signaling to cell death and aging.
Recently, mitochondrial stress has been implicated in the aberrant activation of innate immunity, mediated by
the release of organellar components, such as mitochondrial nucleic acids, recognized by cytosolic sensors as
foreign and potentially dangerous. Aberrant immunity has deep implications in human health and is a driver of
human diseases, such as neuroinflammation and autoimmunity. Mitochondrial immunity has been studied both
in vitro and in vivo, but the complete repertoire of its triggers and effectors has yet to be characterized. I recently
uncovered a previously unknown source of stress conducive to aberrant immunity: stress to the mtDNA in the
form of double-stranded breaks (mtDSBs). The presence of this stressor is relayed to the cytosolic compartment
via mitochondrial herniation, a recently described form of Bax/Bak mediated organelle permeabilization, that
exposes mitochondrial contents to the cytosol. After mtDSBs, mitochondrial RNA – rather than the recipient of
the stress, mtDNA – initiated the innate immunity cascade by activating the sensor RIG-I. Our proposed research
plan builds on this past work to ask essential questions: (1) which sources of mtDNA stress are conducive to
aberrant immunity and what is the impact of dysfunctional mitochondrial transcription or translation; (2) how is
mitochondrial herniation regulated and how does it differ from other forms of mitochondrial permeabilization; and
(3) what are the distinctive features of mitochondrial RNA activation of RIG-I and where do they originate?
Our goal is to understand how mitochondria integrate and translate stress signals, particularly in the
context of innate immunity. My lab will probe different sources of mtDNA stress and interrogate the mechanisms,
effectors, and mitochondrial moieties engaging the cytosolic sensors of immunity. RIG-I is a key protein for the
defense against viruses, but its aberrant activation is involved in both autoimmune conditions and the beneficial
anti-tumor responses elicited by cancer treatments. By building upon our recent findings and prior experience,
as well as by establishing collaborations and seeking the assistance of senior investigators with advanced
expertise in both mitochondrial biology and the key technologies proposed, our research program aims to have
long-lasting impacts on the foundational and translational knowledge of cellular stress responses going beyond
mitochondrial biology into a pathway with further implications in human health and disease: innate immunity.

Public health relevance
Project Narrative (3 sentences, lay) Our present knowledge of mitochondria highlights activities beyond energy production and into their decision- making role in a multitude of cellular processes. While our insight on the essential roles of mitochondrial signaling in disease-relevant processes such as innate immunity is rapidly expanding, several questions remain regarding the origin, mechanisms, and significance of such phenomena. With powerful genetic approaches and cutting- edge technologies, we aim to clarify the relationship between mitochondria and innate immunity, with the potential for paving new therapeutic approaches for human diseases with inflammatory components.